SAFETY/TOLERANCE/ACTIVITY OF MULTIPLE DOSES OF RHU-IL-11 IN CROHNS DISEASE

To demonstrate the safety and tolerability of subcutaneous rhIL-11 in subjects with Crohn's disease; to explore appropriate dosing for future clinical trials, and to define preliminary estimates of biologic activity.